Core C- Data Analysis Core

Core C – Data Analysis Core - Summary/Abstract:
The objective of the Data Analysis Core (DAC) is to provide a comprehensive, multidisciplinary resource for
the research associated with the SPORE. The needs of these projects require a wide breath of biostatistics and
bioinformatics analytical knowledge as well as computational expertise. The DAC will provide biostatistical and
bioinformatic collaboration in support of the discovery, translational, and clinical studies associated with the
SPORE research activities. The comprehensive nature of this core assures each SPORE investigator access to
expertise that includes collaborative development of study designs, collection and management of data,
generation of analysis plans, support for clinical trials, analysis of data, interpretation of data, development of
computational platforms for data mining, and dissemination of results (e.g., abstracts, presentations,
manuscripts). Furthermore, the DAC will facilitate knowledge-sharing among the projects and cores by identifying
and communicating best practices, standardizing data when possible, centralizing data for use across the
projects, and conveying results to SPORE investigators in a timely fashion. Finally, the core is poised to develop
new methodology when needed to support the SPORE research as well as to adapt to changes in research
strategy in response to new or unexpected findings. In summary, to support all proposed SPORE projects, the
Career Development and Developmental Research Programs, the other cores, and related SPORE research,
the DAC will (1) provide biostatistics and bioinformatics collaboration for all SPORE research activities, (2)
facilitate data collection, management, integration, and storage for SPORE research activities, and (3) develop
and implement methodology that enhances the research across the SPORE projects.
The members of DAC will work closely with team members of each of the projects. In addition, they will
collaborate closely with bioinformatics personnel within the research teams of the project PIs to ensure alignment
of the statistical aspects with the bioinformatics efforts and allow the integration of bioinformatics data across
projects. The members of DAC will engage in regular communication with SPORE projects, other Cores, SPORE
PIs.